Multiscale modeling of the role of heme during invasive pulmonary aspergillosis

PROJECT SUMMARY/ABSTRACT
Invasive aspergillosis is among the most common fungal infections in immunocompromised
hosts and carries a poor outcome. The spores of the causative organism, Aspergillus fumigatus,
are ubiquitously distributed in the environment. Healthy hosts clear the inhaled spores without
developing disease, but individuals with impaired immunity are susceptible to a life-threatening
respiratory infection, during which the fungus invades lung tissues, and can then disseminate to
other organs. Aspergillosis is becoming more common and more resistant to antifungal drugs.
Current therapeutic approaches have been focused primarily on the pathogen, but a better
understanding of the components of host defense in this infection may lead to the development
of new treatments against this infection, possibly in combination with antifungal drugs. In the last
funding period, we developed a multi–scale computational model of the host response to
Aspergillus, and used it as a hypothesis-generating tool to guide experiments to understand
mechanisms of iron acquisition during the infection. In the course of these studies, we
discovered that the release of extracellular heme as a result of lung hemorrhage during invasive
aspergillosis is a key mechanism that promotes fungal growth and virulence. Based on our
preliminary data, this renewal application is focused on the inter-connected effects of
extracellular heme on both the host and the fungus, and the effect of this on the course of the
infection. In Aim 1, we will incorporate the role of heme into our existing multi-scale model of
invasive pulmonary aspergillosis, and use the model to mechanistically dissect the contribution
of heme to illness progression in the infection, and in Aim 2, we will determine the contribution
of extracellular heme release to formation of lung neutrophil extracellular traps and the
development of lung injury during invasive aspergillosis. If successful, this project will
mechanistically define the central role of extracellular heme in the pathobiology of invasive
aspergillosis, and serve as a paradigm for the use of mathematical modeling to integrate
complex biological processes and generate rational hypotheses in order to generate new
knowledge.

Public health relevance
NARRATIVE Invasive aspergillosis represents a major and growing health problem in the U.S. and around the world. The growing population of immunocompromised patients, combined with increased resistance to anti-fungal drugs makes it urgent to develop new therapies for this infection, in particular those targeting the host immune response. The proposed project will develop and use advanced mathematical and computational tools, together with extensive experimental data generated using in vivo murine and ex vivo human experimental infections, in order to explore new mechanisms that can be therapeutically targeted in this disease.